Organization of Syncytial Cells

Project Summary
Syncytial cells have multiple nuclei in a shared cytoplasm and are common in the biosphere. These cells are
found in fungal pathogens and symbionts, during embryogenesis of plants and animals, and in bone, blood,
placenta, muscle, and tumor cells of humans. Nuclei sharing a syncytium can differ in genotype, or in gene
expression profile, so that these single cells can approach the functional complexity of a multicellular tissue,
especially when they grow to a large and complex shape. What functions emerge with this form of cell
organization that are distinct from a multicellular tissue? How can a single cell be spatially organized to
support different nuclear identities and functions in a common cytoplasm? My lab’s long-term goal is to
discover the functions of syncytia and to uncover fundamental cell biology that emerges from this unique cell
organization. We have made foundational discoveries in understanding how the nuclear division cycle is spatially
compartmentalized in syncytia. We deciphered how cyclin mRNAs drive the formation of biomolecular
condensates in the vicinity of nuclei and defined fundamental rules for how cells control the location, size and
composition of condensates. The nuclear division cycle is also in part controlled locally by cortical septin
cytoskeleton assemblies that act as signaling scaffolds, controlling the concentrations of cell cycle regulators in
their vicinity. Our recent focus has been on how septins assemble at specific locations in cells. We discovered
that septins preferentially assemble on micron-scale curved membranes, leading them to enrich at specific
locations where cells change shape. The proposed future research in a model filamentous fungus addresses
gaps in understanding how condensates and septins create functional zones for cell cycle signaling within
syncytial cells but also extends to new areas for the lab. In theme 1, we will examine how condensates regulate
translation of cyclin proteins in time and space, dissecting how the material state and composition of condensates
controls protein synthesis. In theme 2, we will determine how different types of septin assemblies recruit sets
of effector proteins to locally control signaling to the cell cycle. This is critical as vanishingly little is known about
the molecular basis for septins as scaffolds. In theme 3, we will examine how the number of nuclei is kept in
balance with the volume of cytoplasm in large multinucleate cells. This is important because pathologies are
associated with aberrant ratios and how all cells sense their size remains a challenging cell cycle puzzle. Finally,
in theme 4, to better understand the functions that emerge from syncytial cell organization, we will assess to
what extent nuclei share or subdivide tasks within the communal cytosol. The flexibility in where and when genes
are expressed, combined with the ability of nuclei to move between different parts of a cell, may be in part the
basis for the wide-spread existence of syncytial cells in the biosphere. In this work, we will enrich our
understanding on form and function of syncytia and illuminate cell organization mechanisms relevant to all cells.

Public health relevance
Project Narrative Syncytial cells contain many nuclei in a common cytoplasm which allows them to achieve large sizes and complex shapes that rival whole tissues. This form of cell organization is found in fungal pathogens, throughout normal human physiology from the placenta to bone, blood and muscles as well as in pathologies. Our work addresses how these cells form and function to understand how the dysregulation impacts diseases as varied as cancer and preeclampsia.